Stakeholder Engagement Studio Core

Project Summary: Stakeholder Engagement Studio Core
The National Center for Engagement in Diabetes Equity Research (National CEDER) Stakeholder Engagement
Studio (SES) Core will expand and enhance the capacity for engaging in partnered research to advance T2D
health equity. The SES Core reflects an equitable partnership between UCLA (MPI Brown) and Visión Y
Compromiso (VyC) (Core Co-Lead Cordero-Bárzaga), and builds on an established history of collaborative
community-engaged research. The core will enrich an already strong foundation of existing community
relationships and stakeholder engagement mechanisms. It will use these to leverage resources from highly
successful partnerships—between researchers, clinicians, community-based organizations (CBOs), and
community members—to spur discovery; new approaches to prevention; and the development of effective
clinical and policy interventions to reduce risk, morbidity, and mortality of T2D-related conditions in diverse
communities. In all activities, the SES Core will support the iterative development of stakeholder engagement
through the Center's activities, in collaboration with the Administrative Core (AC) and Research Consultation
Services (RCS) Core, by promoting a culture of open exchange, equity, inclusion, advocacy, and sustainability.
The SES Core will use a community engagement studio model to improve the quality and relevance of T2D
programs, projects, and research. The overall goal of the SES Core is to deliver studios on the operations and
real-world application of stakeholder engagement in research. Specifically, the SES Core will: 1. Use equitable,
partnered approaches to tailor and modify existing stakeholder engagement studio (SES) models and pilot this
adapted model to improve equity in T2D research, treatment, and prevention interventions; 2. Deliver National
CEDER SES Core services to provide multi-sector stakeholder guidance on socially-, community-, and culturally-
aligned approaches for equitable engagement of diverse communities and individuals in all phases of T2D
research, including partnered study design, recruitment and retention strategies, analysis, and dissemination; 3.
Implement strategic processes to monitor, evaluate, and improve SES services along the research continuum;
and 4. Develop and disseminate recommendations and best practices that advance the translation of
stakeholder-engaged research to achieve equity in T2DM. The SES Core will advance a national model for
partnered research that enhances the quality, rigor, and engagement of diverse communities and stakeholders
in T2D research.